Evaluation of a triple negative matrix signature in tumor progression and resistance

Abstract
Currently there are no available therapies designed to appropriately target the triple negative/basal breast cancer
subtype (TNBC) in Black patients. Due to the risk of recurrence and metastasis following primary therapy, novel
avenues of intervention must be pursued. The tumor matrix, the material cancer cells are grown on, modulates
many aspects of cancer including proliferation, morphology, motility, and survival; however, a link between the
TNBC subtype specific extracellular matrix (ECM) and mechanisms of TNBC tumorigenesis, metastasis, and
drug response has not yet been made. Currently the role for TNBC ECM mediated tumorigenesis and drug
resistance is underdefined in African American patient populations due to a lack of pre-clinical models that
recapitulate the African American TNBC ECM. The following specific aims are designed to test the overall
hypothesis that the use of the TNBC ECM 3D models will provide 1) insight on key ECM proteins that regulate
TNBC tumorigenesis pre- and post- treatment and 2) provide a novel means to understand TNBC ECM mediated
response to therapy. Aim 1 will focus on the evaluation of TNBC ECM from pre- and post- chemotherapy treated
tumors with the goal of understanding TNBC ECM mediated tumorigenesis and metastasis. Aim 2 will focus on
the utility of using TNBC ECM for the interrogation of cellular response to therapy. This will be achieved through
a combination of 3D in vitro screens and murine models of TNBC. In vitro 3D tumor models will be generated to
screen the effects of TNBC ECM composition on the induction of genes associated with tumorigenesis and
metastasis. Specifically, we will evaluate genes associated with a cancer stem-like phenotype, epithelial to
mesenchymal transition, and cellular growth. These in vitro screens will be validated in vivo through the
implantation of seeded 3D scaffolds in the mammary fat pad of SCID/Beige mice and subsequent evaluation of
tumorigenesis and metastasis. Finally, the clinical significance of this study will determine if TNBC ECM derived
from tumors pre- and post- treatment alters response to therapy. TNBC cells grown in our 3D systems will be
evaluated for response to known standard of care therapies via cell survival and kinase activation assays.
Findings from this study will provide insight on both molecular markers for patient prognosis and identify key
matrix proteins as novel drug targets.

Public health relevance
Project Narrative Triple-negative breast cancer (TNBC) ranks among the most aggressive and deadly cancers, demonstrates a high rate of metastasis. The work proposed here seeks to utilize a novel 3D tumor model to understand the matrix influence on TNBC and screen standard of care therapies for the treatment of TNBC. Data from this study will enhance prognostic indicators and identify novel mechanism to re-sensitize drug resistant TNBC to chemotherapy addressing the unmet need of effective treatment options for TNBC.